Discovering novel small molecule drugs through tandem mass spectral database search

Project Summary.
Natural products are the major source of drug molecules. Currently, 64% of small molecule drugs approved by
the Food and Drug Administration are natural products or their derivatives. Currently, the dominant technique for
discovering novel natural products is bioactivity-guided isolation. However, this technique is limited to the high
abundance molecular products of microbial / plant species. Since most of the widely expressed natural products
(NPs) have already been picked, bioactivity-guided techniques now lead to high rediscovery rates of known
molecules. This proposal focuses on developing a novel platform for discovering natural product small molecules
by integrating genome mining with computational metabolomics. With the advent of high throughput tandem
mass spectrometry, metabolomics datasets collected on the supernatant of microbial / plant species have
become available. However, computational techniques for identifying novel small molecules from these large
and complex datasets are in their early stages. Recently, we developed Dereplicator, Dereplicator+, and
molDiscovery to identify known small molecules by searching their tandem mass spectra against public chemical
databases, like PubChem. Currently, there is no computational approach for the systematic discovery of novel
variants of natural product small molecules. Further, manual analysis of such large metabolomic datasets is
infeasible. The existing dereplication-by-molecular-networking strategy is limited to identifying molecules present
in spectral libraries (e.g., NIST library, hundreds of thousands of molecules) but cannot search against chemical
structure databases (e.g., PubChem, hundreds of millions of molecules). To fill this gap, the overarching goal of
this proposal is to develop efficient and accurate methods for identifying novel natural products from complex
mass spectral datasets. We will develop accurate and efficient techniques for variable identification of small
molecules from mass spectra. We will then integrate this method with our existing genome mining approaches
to discover novel natural product small molecules. We will further work with the UM-Natural Products Discovery
Core to collect LC-MS/MS data on culture extracts of 100 Actinobacteria from the U.S. Department of Agriculture.
One NRP with novel chemistries/enzymes will be isolated and characterized at the University of Michigan, and
we will screen them for antimicrobial, antitumor, and antifungal activities.

Public health relevance
Project Narrative. Natural products are an important source of antibiotics, antitumor, and antifungal small molecules. Currently, high-throughput technologies for elucidation of the structure of small molecules are not available. This proposed project will allow us to accurately and efficiently discover novel natural products from complex microbial / plant datasets.